Didactic Interactions

DIDACTIC INTERACTIONS – PROJECT SUMMARY / ABSTRACT
The Didactic Interactions component of the National Center of Neuromodulation for Rehabilitation (NC NM4R)
provides researchers the fundamental building blocks they need through a multi-layered and progressive
program of didactic and experiential learning opportunities supported by complementary components in
mentored collaborations and pilot funding. We offer interactions for researchers with no prior knowledge of
neuromodulation, as well as advanced courses for those with some experience but who desire increased
expertise. Building on the outstanding success of our workshops in the first phase of this grant, the NM4R
Didactic Interactions leadership group have refined guidelines for all learning content for the new grant period.
All sessions, regardless of level, must: 1) be rigorously evaluated for continuous improvement of future offerings;
2) include a hands-on, experiential learning component aimed to increase research rigor and reproducibility; 3)
include a focus on underlying mechanisms of action so that investigators understand why to use a technique
and not just how to do so; and 4) include promotion of synergistic research resources, pilot funding, and follow
on mentored collaboration. Didactic Interactions has three Specific Aims. AIM 1. Provide foundational learning
opportunities in NM4R techniques, methodology, safety, and rigor. Level 1 workshops are the primary tool
for this aim. Adapting to NM4R community needs, we have evolved the curriculum and approach for Level 1
opportunities as new technologies and methods have emerged. The format combines lectures, laboratory
experiences, case discussions centered on key rehabilitation problems, and skills testing leading to enhanced
safety and rigor in research conduct. AIM 2. Develop in-depth and practical knowledge of NM4R approaches
through advanced workshops that include extensive hands-on training based on the participants’
research questions. Building on the knowledge gained from Level 1, Level 2 workshops will focus on in-depth
topics in NM4R – determined by the research interests of the national community. In addition to the advanced
didactic content, participants will bring their own research questions and co-learn with leaders and colleagues to
hone their hypotheses, skills, and methods to assist in translating their approach into an evidence-based
neurorehabilitation intervention. AIM 3. Develop unique interdisciplinary training opportunities that
stimulate the NM4R community’s technology development, creativity, and clinical translation. We will
develop symposia, with didactic, and hands-on learning, to bring investigators from diverse fields together to
explore novel and advanced applications of NM4R approaches to address priority areas identified in the RPR.